Role of meningeal lymphatic vasculature in neuroimmune communication development

The objectives of the proposal are to determine, for the first time, how developing meningeal
lymphatic vessels (MLVs) impact neuroimmune communication in early postnatal life, and if MLV-
dependent neuroimmune communication can be harnessed by VEGF-C signaling in young mice
at steady state and in a model of pediatric brain tumor such as medulloblastoma, the most
common tumor affecting children.
Our previous work and preliminary data show that MLVs develop during early postnatal life,
that their growth requires Vascular Endothelial Growth Factor-C (VEGF-C) and the VEGF-C co-
receptor Neuropilin2 (Nrp2), and that enhancing MLV growth enables adaptive immune
responses against glioblastoma in the adult. These findings prompt us to investigate mechanims
how MLV-mediated neuroimmune connection establishes and to characterize the transport of
antigen-presenting cells (APCs) to CNS-collecting lymph nodes (cLNs) and the MLV-dependent
education of T cells in developing cLNs.
Experimental approaches to successfully complete this project include new lymphatic-specific
knockout lines, new procedures of three-dimensional whole-head imaging by light sheet
fluorescence microscopy, and unbiased molecular analysis by mass spectrometry and single cell-
RNA sequencing.
This multidisciplinary study will bring together complementary expertise in the fields of
meningeal lymphatics (Jean-Leon Thomas, Yale), developmental angiogenesis (Anne Eichmann,
Yale), and immunology (Akiko Iwasaki, Yale), with additional advisors in pediatric oncology (Asher
Marks, Director of Yale Pediatric Neuro-Oncology), liquid-chromatography mass spectometry
(Tukiet Lam, Director of Keck MS & Proteomics Resource at Yale), and TCR repertoire analysis
(Le Zhang, Yale Neurology).
We expect to characterize the development of MLV-dependent neuroimmune communication,
to identify Nrp2 as a new mandatory regulator of MLV sprouting, identify APC subpopulation(s)
required for CNS antigen transport into cLNs, and to determine, as a proof of principle, the
potential of VEGF-C-driven MLV growth to promote early T cell education against abnormal CNS
antigens, with perspectives for the treatment of aggressive pediatric brain tumors.

Public health relevance
We propose to establish how meningeal lymphatic vessels mediate neuroimmune communication in the developing brain, and how they can be harnessed to enhance early T-cell education in a mouse model of pediatric brain tumor. We will use unbiased approaches, based on new mouse genetic models and cutting-edge molecular and imaging techniques that we have established, to manipulate meningeal lymphatic growth, assess their role in the transport of brain-derived molecules and in the traffic of antigen- presenting cells, and investigate mechanisms leading to T cell reponses in the collecting lymph nodes. Our results will enhance knowledge in this understudied area and may lead to novel translational approaches to combat pediatric brain tumors by increasing neuroimmune communication via meningeal lymphatics, and by boosting tumor antigen transport, T cell priming and anti-tumor effector function.